THEORETICAL CHEMISTRY AND POLYMERS

Theoretical work is proposed on polymer molecules in solution and in various bulk phases. The main areas are polyelectrolyte theory, computer simulation of polymer dynamics, and the development of self-consistent field theories of motion in bulk polymer phases.